Alcohol use and sexual violence among college students with disability – co-creating inclusive research and prevention (Administrative Supplement NOT-OD-24-031 to R01 AA023260)

In response to the call for research on bioethical issues to guide health-related, behavioral science research
(NOT-OD-24-031), this administrative supplement will focus on processes to support co-creation of multi-level
interventions for students with disabilities (SWD) to address the nexus of sexual violence (SV) exposure and
heavy drinking. The alcohol misuse common on American college campuses is particularly harmful for SWD,
putting them at even higher risk for intimate partner violence (IPV) and SV victimization than other students.
From our team’s prior work, over a quarter of students seeking care in college health and counseling centers
(CHC) endorsed having at least one disability, and of those students, over three quarters had experienced IPV
or SV in their lifetime. Yet no interventions exist that address the specific and unique needs of SWD and that
offer harm reduction strategies to reduce risk for violence exposure and alcohol misuse (i.e., heavy episodic
drinking and excessive alcohol use). Particularly challenging for research and intervention development is the
continued ‘invisibility’ of disabilities, the stigma associated with disabilities, intersections with other forms of
marginalization such as racism, homophobia, and transphobia, and limited patient and community engagement
in alcohol research. Thus, the bioethical issues to be addressed in this proposal are: 1) development of a
shared framework for conducting research with college SWD designed with SWD and other constituents, and
2) identifying accessible human-centered design strategies to ensure full inclusion of SWD in co-creating
prevention interventions. This study leverages the parent study, a cluster randomized controlled trial of an SV
prevention program across 20+ college campuses in the U.S. (R01 AA023260, PI Miller). The parent study
supports a community of practice across these diverse campuses with campus administrators, those
responsible for accessibility services, diversity and inclusion, student safety, sexual assault prevention, alcohol
and drug counseling, student health services including counseling, and learning supports. Additionally, through
connections with student health and counseling centers, the parent study will facilitate recruitment of this
harder-to-reach population as well as campus personnel with expertise in serving students with disability to
participate in proposed study procedures. We will identify key ethical considerations for conducting research
with college SWD to guide college campus behavioral health research (Aim 1). We will implement accessible
human-centered design sessions with key constituents to co-create multi-level prevention interventions
focused on healing-centered supports for SWD (Aim 2). These aims are expected to contribute to research on
bioethical issues. First, the listening sessions will yield a toolkit to guide inclusive research practices that
center SWD. Second, the interventions that are co-created will be compiled in a community-partnered report
on recommendations from SWD on a) how to conduct accessible human-centered design sessions, and b)
ideas for inclusive prevention practices including strategies to increase provider competencies in serving SWD.

Public health relevance
In response to the call for research on bioethical issues to guide health-related, behavioral science research (NOT-OD-24-031), this proposed administrative supplement will focus on the processes necessary to co- create multi-level interventions for students with disabilities (SWD) to address the nexus of sexual violence (SV) exposure and heavy drinking. Particularly challenging for research and intervention development is the continued ‘invisibility’ of disabilities, the stigma associated with disabilities, intersections with other forms of marginalization such as racism, homophobia, and transphobia, and limited patient and community engagement in alcohol research. Thus, the bioethical issues to be addressed in this proposal are: 1) development of a shared framework for conducting research with college SWD designed with SWD and other constituents, and 2) identifying accessible human-centered design strategies to ensure full inclusion of SWD in co-creating prevention interventions that increase protective factors and reduce exposure to violence and alcohol misuse.